NEUROPSYCHOLOGICAL/PERSONALITY INDICATORS OF RISK

The proposed study builds upon our previous work that has characterized male and female adolescents in relation to their risk for developing alcohol related problems, including dependence. Following from a modified version of Sher's 'deviance prone' model of vulnerability, several aspects of neuropsychological functioning, temperament, and cognitive style will be examined as possible mediators/moderators of the risk for developing alcohol problems due to a paternal history of alcoholism. In this proposed model, temperament includes personality traits as well as antisocial personality disorder. These moderators/mediators of risk will be examined in relation to several intermediate outcomes (e.g. alcohol/drug use, school, family, social problems) in 200 adolescents, aged 16-18 years old using a balanced 2 x 2 x 2 design (family history positive for alcoholism / family history negative for alcoholism; ASP [or ASP spectrum ]/ no ASP; male / female. The specific aims of the proposed project are: 1) to determine whether there are subtle neuropsychological differences, particularly those hypothesized to be associated with frontal lobe functioning, that distinguish FH+ and FH- adolescents; 2) to examine the influence of gender as a modifier of the effects of FH+ or ASP on the different areas of neuropsychological functioning; 3) to determine whether several aspects of temperament (e.g. personality traits, cognitive appraisals) can distinguish adolescents at different levels of risk for pathological alcohol use; 4) to examine aspects of temperament (e.g., neuroticism and affect intensity) in relation to neuropsychological functioning among adolescents at different levels of risk due to a family history of alcoholism or ASP; 5) to determine whether subtypes of ASP (possibly related to gender) are associated with variations in alcohol/drug use in adolescents; 6) to establish a basis for a prospective, longitudinal investigation of the putative risk factors leading to the development of alcohol dependence. In summary, the proposed study will examine mechanisms underlying the parent-offspring transmission of alcoholism, the initial course of early drinking problems, and the consequences of having an alcoholic father in adolescence.